Center to Improve System Performance of Substance Use Disorder Treatment

This Core Center of Excellence application (P30) for the renewal of the Brandeis/Harvard Center to Improve
System Performance of Substance Use Disorder Treatment proposes to enhance the effectiveness and
impact of existing research on delivery and payment of substance use disorder (SUD) treatment services, and
offer a national resource for those researching and designing SUD treatment systems and policy in the context
of ongoing, dramatic changes in the US health care system. The Center’s goal is to conduct and extend
research on service delivery and payment to synergistically expand the research base, informing policy and
practice decisions that will profoundly affect the cost, quality, and availability of SUD services. The intertwined
nature of delivery and payment systems requires attention to both in order to achieve sustainability of high
value systems innovations. While continuing to emphasize innovations in delivery and payment systems
broadly defined, the proposed renewal will also bring intentional focus to low-barrier settings for treatment (i.e.,
wholly outside of or extensions of specialty SUD settings such as emergency departments, pharmacies, and
telehealth), as well as quality improvement, inequities in the provision and financing of services, and factors
that influence sustainability of innovation. The renewal also will expand the science around Medicaid managed
care, given the importance of Medicaid as a payer of SUD services, and the dominant role of private Medicaid
health plans. The Center will build on three Component research projects, as well as related research at
Brandeis, Harvard and elsewhere, and support the development of new research to provide crucial and timely
evidence that can inform the design and implementation of effective policy and practice. The Administrative,
Research, Policy/Dissemination, and Pilot/Mentoring Cores provide the organizational engine to promote
cross-fertilization of findings across projects to support the Center’s aims: 1) advance the science by
conducting and stimulating research and knowledge development about payment and delivery system
innovation for SUD treatment; 2) drive the next generation of research by mentoring and training a
racially/ethnically diverse pool of early career investigators and creating networks of early career and senior
researchers; and, 3) engage with key stakeholders in a bidirectional exchange to produce timely and relevant
research that informs and influences policy and practice. The Center will achieve these aims by extending the
research base to include critical analyses of timely and emerging topics identified in close collaboration with
key stakeholders. We will do this through activities that include empirical and conceptual papers; short- and
longer-term analyses targeted at pressing issues for policy and practice; and multiple mentoring programs and
activities to support early career investigators. Further, we will translate and disseminate findings to an
expansive audience of policy makers, payers, providers, persons with lived experience of SUD, and
researchers to inform the changing environment of delivery and payment of SUD treatment services.

Public health relevance
This Core Center of Excellence (P30) application for the renewal of the Brandeis/Harvard Center to Improve System Performance of Substance Use Disorder Treatment proposes to conduct and extend research on SUD service delivery and payment methods to synergistically expand the research base – serving as a national resource to inform research as well as policy and practice decisions that will profoundly affect the cost, quality, equity and availability of SUD treatment services – and supporting early career investigators in addiction health services research. The Center fills a critical public health need to better understand how to improve performance of the SUD treatment system.